Subclinical CVD in African American Type 2 Diabetics

DESCRIPTION (provided by applicant): Relative to European Americans (EAs), African Americans (AAs) have higher rates of myocardial infarction, possibly reflecting poorer access to healthcare. In contrast, when provided equal access to healthcare, AAs have 50% lower myocardial infarction rates than EAs. A related observation is that AAs have markedly less subclinical cardiovascular disease (CVD) measured as coronary artery calcified plaque (CAC). This occurs despite the presence of more severe conventional CVD risk factors in AAs. CAC predicts future risk of myocardial infarction. A paradigm shift developed based on our earlier finding that AAs are at lower biologic risk for developing CAC (and associated myocardial infarction) than EAs. Genetic polymorphisms exhibiting different frequencies between population groups likely contribute to the racial difference in CAC, as well as presence of novel CVD-associated factors including bone mineralization and serum vitamin D levels, both associated with CAC. This project targets the pathogenesis of CAC by focusing on racial differences in subclinical CVD with emphasis on the understudied relationship between bone health, vitamin D, and CAC. AAs also manifest lower rates of osteoporosis despite lower vitamin D levels and ingestion of less dietary calcium than EAs. There remains a critical need to collect longitudinal data tracking changes in CAC and bone mineral density in relation to vitamin D and assess the importance of these factors in AAs who are at high CVD risk. This renewal application proposes to: (1) longitudinally measure CAC and bone mineral density, and their relative association with novel CVD-associated factors including serum vitamin D and bone metabolism in African American-Diabetes Heart Study (AA-DHS) participants, among the most extensively phenotyped AA cohort with type 2 diabetes~ (2) explore the roles of novel CVD risk factors on development and progression of CAC~ and (3) identify the genetic variation that contributes to lower rates of CAC in AAs. The presence of diabetes in our unique AA-DHS cohort likely contributed to their higher CAC scores. Follow-up exams in the well phenotyped and genotyped AA-DHS cohort will provide critically important data which will increase our understanding of CVD risk in AAs. Our diabetes-duration matched sample of 1,200 EAs recruited in the Wake Forest Diabetes Heart Study with genome-wide association data will allow for rapid replication of genetic associations with CAC in AAs. The roles of vitamin D and bone metabolism on development and progression of CAC are of intense interest, as controversy surrounds supplemental vitamin D in AAs due to potential injury to coronary arteries and bone. Exploring links between genetic risk, bone health and vitamin D will improve our understanding of subclinical atherosclerosis in AAs and aid in development of novel treatment and prevention strategies. PUBLIC HEALTH RELEVANCE: Epidemiological studies in more than 600,000 Kaiser Permanente and Veterans Administration patients reveal that African Americans with access to adequate healthcare are at lower risk for myocardial infarction than European Americans, an observation supported by population-based and clinical studies revealing substantially less coronary artery calcified plaque (CAC), also known as subclinical cardiovascular disease, in African Americans. Racial differences in the frequencies of genetic risk variants for coronary artery disease and novel cardiovascular disease risk factors including serum vitamin D levels and bone mineral density appear to be associated with the lower biologic risk of myocardial infarction and CAC in African Americans. This renewal application of RO1 DK071891 proposes to collect critically necessary date involving longitudinal change in CAC, bone mineral density, and serum vitamin D levels, and perform genetic analyses in African Americans at high risk for myocardial infarction to detect novel factors associated with susceptibility to (and protection) from CAC that can be applied to members of other race groups.

Public health relevance
Epidemiological studies in more than 600,000 Kaiser Permanente and Veterans Administration patients reveal that African Americans with access to adequate healthcare are at lower risk for myocardial infarction than European Americans, an observation supported by population-based and clinical studies revealing substantially less coronary artery calcified plaque (CAC), also known as subclinical cardiovascular disease, in African Americans. Racial differences in the frequencies of genetic risk variants for coronary artery disease and novel cardiovascular disease risk factors including serum vitamin D levels and bone mineral density appear to be associated with the lower biologic risk of myocardial infarction and CAC in African Americans. This renewal application of RO1 DK071891 proposes to collect critically necessary date involving longitudinal change in CAC, bone mineral density, and serum vitamin D levels, and perform genetic analyses in African Americans at high risk for myocardial infarction to detect novel factors associated with susceptibility to (and protection) from CAC that can be applied to members of other race groups.